Family-Based Prevention to Promote the Social-Emotional Functioning and Healthy Lifestyle Behaviors of Black & Latinx Children

Preventive interventions with minoritized families have rarely included content to promote ethnic-racial
socialization (i.e., how families teach their children about the values, traditions, and practices associated with
their ethnic-racial group). Ethnic-racial socialization plays a key role in mitigating the negative effects of racism
on health outcomes and in contributing to children’s social-emotional functioning and healthy-lifestyle
behaviors. This omission represents a crucial gap that may be limiting the engagement, reach, and impact of
preventive interventions with minoritized families. Furthermore, the prevention and family intervention fields
have focused on either social-emotional functioning or healthy lifestyle behaviors, rather than integrating the
two domains. Addressing each domain in a separate intervention misses the synergistic effects and is less cost
effective than tackling both domains using a single, integrated intervention. To address these gaps, the main
objective of this project is to test whether providing parenting support, with an added emphasis on ethnic-racial
socialization and healthy lifestyle behaviors, improves the social-emotional functioning and healthy lifestyle
behaviors of Black and Latinx children ages 3-6. The guiding hypothesis is that incorporating these
components into a parenting intervention will lead to improvements in children’s health as compared to a
control condition. This pilot project is novel in that it (a) interweaves positive parenting practices, ethnic-racial
socialization, and healthy lifestyle behaviors into a prevention program for Black and Latinx families, and (b)
targets preschool aged children using a brief, universal prevention approach, which increases potential for
dissemination and scalability. A type 1 hybrid effectiveness-implementation design is used to simultaneously
test intervention effectiveness while also gathering information on intervention delivery to inform future
implementation trials. The specific aims are to: (a) test the preliminary effects of a preventive intervention on
the social-emotional functioning and healthy lifestyle behaviors of Black and Latinx children, (b) identify the
preliminary effects of the intervention on parenting outcomes, and (c) examine potential barriers and facilitators
to intervention delivery. The expected contribution of this project is to provide important foundational
knowledge regarding whether ethnic-racial socialization and healthy lifestyle behaviors can be integrated into a
brief parenting intervention to enhance minoritized children’s physical and emotional health. This contribution is
significant because it can lead to advancements in prevention efforts focused on improving child health-related
outcomes, potentially decreasing health disparities for minoritized children.